Insights into Structure-Function Relationships of Matrix Metalloproteinase-1 from Computational and Experimental Studies

PROJECT SUMMARY
Changes in the activity of collagenolytic matrix metalloproteinase-1 (MMP-1) have been linked to
the progression of breast and lung cancer, leukemia, and melanoma. A complete understanding
of MMP-1’s structure, mechanism, and function will aid the development of specific inhibitors of
MMP-1 for treating diseases that have significant societal impact. The overarching goal of the
proposed research is to provide the missing knowledge about conformational and mechanistic
aspects of structure-function relationships in MMP-1 and to explain the effects of disease-related
mutations in triple-helical peptide (THP) collagen models and MMP-1 at an atomistic level. The
central hypothesis, supported by preliminary studies, is that MMP-1 collagenolysis critically relies
on complex conformational changes that involve the enzyme's main structural elements and the
THP. We further hypothesize that long-range correlated interactions with remote residues can
control the catalytic mechanism of MMP-1. The goal of the proposed research application will be
accomplished by two specific aims: Aim 1: What is the mechanism of product release after
collagenolysis of the THP’s leading (L) chain? The study will determine the structural changes
and energetics associated with the release of the product of the collagenolysis of the L chain of
THP. Aim 2: What is the catalytic mechanism of collagenolysis of THP’s middle (M) and trailing
(T) chains? The goal of Aim 2 is to model the catalytic mechanism of THP’s middle (M) and trailing
(T) chains collagenolysis by means of combined quantum mechanics/molecular mechanics
(QM/MM) methods and to validate the model using experimental measurements. The research
adopts a novel approach by integrating state-of-the-art multilevel molecular modeling approaches
in synergistic combination with experimental methods., thus offering unique opportunities for
training undergraduate students in promising directions of biomedical research.

Public health relevance
PROJECT NARRATIVE Abnormal collagenlysis leads to the development of pathological conditions, however the intimate mechanism of this process remains unknown. The proposed research will reveal the mechanism of collagenolysis, catalyzed by Matrix Metalloproteinase I (MMP-1) that can help for the development of novel therapeutic agents.